Evaluation of Clinical Effectiveness, Cost, and Implementation Factors to Optimize Scalability of Treatment for Co-Occurring SUD and PTSD Among Teens

Psychosocial traumatic events, and interpersonal violence experiences in particular, during childhood serve as
strong and consistent predictors of substance use problems (SUP) during adolescence and adulthood. PTSD
that extends from such IPV often co-occurs with SUP. Despite this well-established link, standard care for
adolescents with co-occurring SUP and PTSD for the last several decades has been to treat these problems
separately. This compartmentalized approach to treatment creates burden on teens and families, raises unique
challenges to clinicians in both mental health and addiction domains, and may contribute to high rates of SUP
relapse among adolescents with co-occurring PTSD. To address this problem, our team recently completed a
rigorous NIDA-funded randomized controlled trial (RCT) supporting the efficacy of an integrative, exposure-
based treatment we developed, Risk Reduction through Family Therapy (RRFT), in greater long term reductions
in SUP, as well as PTSD avoidance and hyperarousal symptoms, in comparison to standard treatment in a large
teen sample. The proposed RCT, with an effectiveness-implementation Hybrid Type I design, substantially builds
on that prior research by proposing to: 1) evaluate whether RRFT's clinical effectiveness for reducing SUP and
PTSD can be extended to youth in outpatient substance use treatment settings—where youth are presenting for
SUP treatment and where clinicians often have less experience treating PTSD (Aim 1); 2) evaluate the cost-
effectiveness of RRFT and to explore inner context variables (e.g., perceived treatment acceptability, attitudes,
and satisfaction among the participating adolescents, caregivers, agency leaders, and therapists and barriers to
and facilitators of implementation) that might affect RRFT implementation in diverse practice settings (Aim 2).
The proposed effectiveness-implementation trial will recruit adolescents (13-18 years) with a history of IPV
presenting with SUP and PTSD symptoms for outpatient substance use disorder treatment at sites in Denver,
Colorado affiliated with NIDA's Clinical Trials Network. Participants will be urn randomized to RRFT or Treatment
as Usual. A multi-method, multi-respondent approach will track clinical outcomes (SUP, PTSD, and putative
targets of treatment, such as emotional suppression) at 3, 6, and 12 months post-baseline. To reduce the
science-to-practice gap, as an Exploratory Aim, we will assemble and engage an Advisory Board of leaders
from Colorado state departments (Offices of Behavioral Health and Criminal/Juvenile Justice for Colorado, which
have committed to participate) and community mental health organizations that oversee policy and decision-
making in selection and implementation of psychosocial treatments for high-risk adolescents, with the goal of
building capacity for large scale (e.g., state-wide) uptake of evidence-interventions for teen SUP and PTSD, like
RRFT, upon completion of the grant. This proposal is directly in line with NIDA's recent release of NOT-DA-20-
004, a Notice of Special Interest encouraging research on comorbid substance use, substance use disorders,
and other psychiatric disorders.

Public health relevance
The results of the proposed study will have a significant impact on public health by providing critical information regarding the clinical and cost effectiveness of the only empirically-supported treatment to date (Risk Reduction through Family Therapy; RRFT) for adolescents with co- occurring substance use problems and PTSD symptoms. If these problems are left untreated, adolescents with interpersonal violence histories are at high risk for addiction and severe mental health disorders as they enter young adulthood and across the lifespan. Demonstrating the clinical and cost effectiveness of RRFT and more closely examining the qualitative factors that would assist in its implementation broadly, as well as engaging policy makers and brokers to work toward large scale uptake of evidence-based treatment for this population among front-line clinicians, would substantially improve practice for this population.